Calling germline and mosaic variants from long genomic and RNA-seq reads

PROJECT SUMMARY
The rapidly reduced cost and increased base quality of long sequence reads enable the accurate calling of
germline and mosaic sequence variations thanks to phasing and the power to resolve repetitive regions.
Although multiple callers have been developed for long-read variant calling, tools are still missing for several
important applications such as variant calling from long RNA-seq reads, mosaic small variant calling for long
reads and accurate mosaic structural variant calling. In addition, existing tools often target one type of variants
and treat small variants, structural variants and phasing as separate problems. This reduces the power of long
reads and makes the current tools difficult to use for biologists. Here, we plan to address these issues with
three proposals: (1) developing a variant caller for calling germline variants, mosaic mutations and RNA editing
events from long RNA-seq reads; (2) improving the accuracy of mosaic and somatic structural variant calling
using pangenome graphs and the de novo assembly of the normal bulk sample; (3) jointly calling
germline/mosaic small/structural variants from long genomic reads by using integrated phasing and local
realignment or reassembly methods. Upon completion, this proposal will result in new computational tools for
tasks not achievable with current methods and for the calling of most types of variants to higher accuracy.

Public health relevance
PROJECT NARRATIVE Accurately calling genetic variants from high-throughput sequence data may be critical to the understanding of the phenotypes and to the clinical decision. The proposed studies aim to develop novel variant calling algorithms for accurately calling most of types of germline and mosaic variants from long sequence reads. The success of the proposal is likely to enhance the study of mosaic mutations and structural variants in biomedical research.